Salivary biodegradation modulates oral microcosm biofilms on bonded dental restorations

PROJECT SUMMARY/ABSTRACT One of the most common reasons for the replacement of dental restorations is recurrent (secondary) caries at the gingival tooth-restoration interface. Human salivary enzymes such as esterases hydrolyze dental resins to produce biodegradation products. A two-fold approach is proposed wherein: 1] the degradation of composite and adhesive resins will be characterized after long-term salivary esterase exposure, and 2] the impact of long-term salivary esterase exposure on biofilm structure and growth will be characterized. This proposal offers a novel in vitro approach that correlates surface degradation of resins with oral biofilm formation under clinically relevant conditions. The methodology proposed will be beneficial for the testing of future resin composite and adhesive resin formulations, and could easily be adapted to assess biodegradation in other types of biofilms. The proposed project will benefit dental and dental hygiene students by exposing them to research, and will strengthen the research environment of an educational institution that has not been a major recipient of NIH funds, which are the goals of the R15 (AREA) award.

Public health relevance
PROJECT NARRATIVE The cost of replacing direct resin restorations is estimated to be in the billions of dollars and is increasing annually. The knowledge gained from the proposed research will provide fundamental information about the long-term growth of biofilms on dental composite and adhesive resins when subjected to salivary esterase-mediated biodegradation, as experienced by restorations after placement in the mouth.